Operations and Collaborations Center - Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) Operations and Collaborations Center (UM2 Clinical Trial Optional)

ABSTRACT – OPERATIONS AND COLLABORATIONS CENTER (OCC)
The primary goal of the Operations and Collaborations Center (OCC) for the Adolescent Medicine Trials
Network for HIV/AIDS Interventions (ATN) is to provide overall support for the ATN research program. The
ATN OCC will work collaboratively with the ATN Scientific Leadership Center and the Executive Committee
(EC) in developing and implementing the ATN scientific agenda through establishing and maintaining the ATN
operational infrastructure, providing organizational support, and ensuring site consortium (SC) capacity for the
ATN's research projects and with external collaborations. The specific aims for the OCC are: (1) support the
ATN infrastructure including facilitate ATN-wide communications, support the EC and formation of
subcommittees, schedule and organize routine and ad hoc meetings, including semi-annual Network meetings;
and assemble and convene the ATN External Scientific Panel at least annually; (2) train SCs on research-
related topics including regulatory, Investigational New Drugs (INDs)/investigational device exemption (IDE),
safety reporting, good clinical practice/good clinical laboratory practice, human subjects protection, quality
control (QC), and quality assurance procedures; (3) create mechanisms to monitor subject recruitment,
retention, and dropout, and develop procedures for adjustment if enrollment targets are not being met; (4) build
a detailed system to track and report study progress to the ATN EC and the National Institutes of Health,
including a description of performance metrics, milestones, timelines, and QC measures, and strategies to
identify and mitigate any issues; (5) liaison with the ATN EC to produce and maintain a Network Manual of
General Operations, including standard operating procedures and policies; (6) provide and lead full regulatory
structure to support all ATN and cross-network investigational (IND/IDE) clinical trials; (7) Maintain the ATN
protocol disbursement fund and execute all necessary agreements to support site-specific subject accrual visit
reimbursement, reconciling reimbursement with site performance, recruitment, and retention; (8) manage ATN
resources and execution of performance-based subcontractors such as material distributors, specimen
storage, pharmaceutical vendors, investigators; (9) develop and maintain a publicly accessible and restricted
website to share information among the ATN and collaborating investigators; (10) establish and support a
National Community Advisory Board (CAB) and provide logistical support for all CAB activities and meetings;
(11) develop and support cross-network protocols, collaborations, and other projects, including the conduct of
trainings and development of manuals of procedures, facilitating communications and conference calls; (12)
oversee SCs, and support staffing and structure modifications as necessary to meet the evolving needs of
research protocols; and (13) collaborate fully and with transparency, including appropriate sharing of all
necessary tools, materials, technologies and other essential methodologies necessary for protocol and
program development, implementation, and monitoring across the Network and with other networks.

Public health relevance
PROJECT NARRATIVE – OVERALL The Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) develops and conducts innovative behavioral, community-based, translational, therapeutic, microbicide, and vaccine trials in youth ages 13-24 at risk for HIV and living with HIV, with a focus on the inclusion of minors. This initiative centers on collaboratively conducted interventional research aimed at reducing new HIV infections and investigating HIV treatments in this disproportionately medically underserved, gender and racial/ethnic minority, and/or substance abusing youth population. The ATN OCC facilitates transdisciplinary research through organizational leadership and collaboration support for the ATN-specific agenda that addresses substantial and disproportionate gaps in health outcomes across the HIV prevention and care continuum for youth.